Motion Compensated fMRI for Pre-Surgical Planning in Epilepsy

Project Summary
Epilepsy affects about 1% of people, and one-third of cases do not respond effectively to drug treatment.
Patients with drug-resistant epilepsy are candidates for surgical resection of the epileptogenic zone, a
potentially curative treatment. Clinical functional MRI plays a critical role in planning for neurosurgery in
epilepsy. FMRI provides data to localize eloquent cortex, to assess the risks and benefits of a planned surgical
resection, and to allow a resection to be tailored to the individual patient. The primary challenge to acquiring
high quality functional MRI is motion of the participant. Motion reduces the temporal signal-to-noise ratio
(tSNR) by misaligning the BOLD signal, motion creates spin history artifact, and motion can move parts of the
brain out of the imaging field of view. These artifacts in turn lead to both false positive and false negative
detections of functional activity, which compromise the fidelity of functional localization. This is usually detected
and corrected to the extent possible, by discarding motion corrupted data, and using only motion-free
segments. Since sufﬁcient data must be acquired for such an analysis, fMRI acquisitions are designed to
acquire redundant data to allow for loss to motion. At our institution, and others, this additional imaging time
alone has been estimated to more than double the cost of fMRI imaging studies. The loss of fidelity and
increased cost due to motion compromises the utility of the fMRI in planning for surgery. This is especially
critical in patients who have difficulty following instructions, such as elderly, ill, or pediatric subjects. There is an
unmet need for improved motion monitoring, prospective and retrospective correction for motion for fMRI. To
improve the utility and decrease the cost of fMRI, we propose to develop, apply and evaluate novel technology
to enable real-time self-navigated motion monitoring and improved correction for fMRI, through the following
four specific aims: Aim 1: Develop and evaluate reduction of motion enabled by real-time slice-by-slice motion
monitoring during fMRI; Aim 2: Develop and evaluate the reduction of motion artifact from slice by slice
retrospective motion correction; Aim 3: Develop and evaluate the reduction of motion artifact from real-time
slice by slice prospective motion correction (PMC); Aim 4: Assess the utility of motion monitoring, retrospective
motion correction and prospective motion correction for improving functional MRI for planning for epilepsy
surgery.

Public health relevance
Project Narrative Echo planar fMRI is widely used at our institution, and others, for functional localization for patients who are candidates for surgical resection to treat epilepsy. This project will develop and assess accurate, real-time, self-navigated slice-by-slice motion monitoring, retrospective and prospective motion correction strategies to substantially improve the quality of fMRI. These new sophisticated technological advances will enable the reduction of the duration of fMRI scans, and ensure the collection of sufficient high quality data free of motion artifact which in turn will enable improved localization of function. These advances will ultimately increase the quality and utility, and decrease the cost, of fMRI for planning the effective use of surgery to cure epilepsy.